Biasing Mu Opioid Receptor Signaling in vivo

Summary
Prescription opioid narcotics, such as morphine, oxycodone, and fentanyl, produce analgesia and side
effects through activation of the mu opioid receptor (MOR), a G protein coupled receptor (GPCR). Our long-
standing goal is to understand how MOR signals to produce distinct biological effects and to ultimately
influence the development of therapeutics that will take advantage of “good” receptor signaling (pain relief)
and avoid “bad” receptor signaling that leads to unwanted opioid side effects like respiratory suppression and
tolerance. It has become increasingly evident that different drug structures can elicit different receptor
signaling cascades at a single receptor, likely by changing the affinities for association with intracellular
binding partners. Over the past decade, we have developed a series of agonists that act in a manner that
drives G protein signaling downstream of MOR and induce little interactions between the receptor and
arrestin2, a scaffolding protein. Moreover, we have determined that several of these agonists produce
antinociception without inducing respiratory suppression. One compound, SR-17108 has been shown to be
potent and efficacious in a neuropathic pain model where it performed better than oxycodone or morphine.
Chronic treatment with SR-17018 did not lead to tolerance in the mouse models. Extensive biochemical
studies have recently revealed that at least 4 agonists from this class, including SR-17018, are binding to
different sites on the receptor and are therefore noncompetitive or allosteric agonists. In this proposal, we
want to determine if it is this noncompetitive property, or other pharmacological properties that the
compounds possess that confer the favorable physiological profiles. Further, we are seeking to determine
the binding site of these compounds. Since the compounds bind to different sites on the receptor than
conventional opioid drugs, we will ask how the allosteric compounds interact with morphine, fentanyl and
naloxone when administered together.

Public health relevance
Project Narrative: Our goal is to parse apart opioid-induced side effects from opioid-induced pain relief by developing new drugs that act differently at the opioid binding site on cells, the mu opioid receptor. The compounds that we have developed bind to the mu opioid receptor in a different way than morphine and fentanyl; moreover, they produce pain relief in rodents and primates at doses that do not produce respiratory suppression, the primary cause of opioid overdose. Herein we propose to understand how these new compounds interact with the receptor from a mechanistic perspective and how they will act in combination with known opioids such as fentanyl and morphine.